Molecular basis of brush border assembly

SUMMARY
Differentiating enterocytes build ~3000 microvilli on their apical surface and organize these protrusions into an
array referred to as the brush border (BB). BB microvilli exhibit perfect tight packing and this unique morphology
is critical for maximizing the number of protrusions, the holding capacity for membrane associated transporters
and channels, and in turn, the functional capacity of the cell. The physiological importance of the BB is
underscored by the fact that numerous intestinal diseases that are linked to the destruction and/or malformation
of microvilli. Our group has made fundamental discoveries on mechanisms that enterocytes use to organize
microvilli into functional, ordered BB arrays. Groundbreaking studies from our group identified two BB-specific
protocadherins, CDHR2 and CDHR5, which form a heterophilic intermicrovillar adhesion complex (IMAC) that
links the tips of adjacent microvilli and promotes ordered packing on mature villus enterocytes. Importantly, our
work with CDHR2 KO mice established that loss of IMAC function leads to ~35% fewer microvilli on the apical
surface and a corresponding growth rate reduction at the whole animal level. How IMACs drive the accumulation
of thousands of microvilli over time during enterocyte differentiation remains the critical open question that we
will tackle in this proposal. In exciting preliminary ultrastructural studies, we discovered that crypt microvilli initially
exhibit robust accumulation at cell margins, which implies the existence of a mechanism for anchoring nascent
protrusions at these sites. We also observed similar marginal accumulation of microvilli on the surface of
differentiating intestinal and kidney epithelial cell lines. In all models examined, microvilli extending from one cell
span intercellular space to make physical contact with microvilli on a neighboring cell. Remarkably, super-
resolution microscopy of native tissue and epithelial culture models showed that microvilli in these contacts
contain both CDHR2 and CDHR5, suggesting they represent transjunctional IMACs, a novel form of epithelial
cell-cell contact. Using a cell mixing approach to drive the formation of transjunctional IMACs, photobleaching
measurements revealed that transjunctional IMACs are much longer lived vs. medial IMACs. Finally, we learned
that CDHR2 loss-of-function models, which are unable to form IMACs, exhibit defects in tight junctions. These
initial findings lead us to propose the following hypothesis: transjunctional IMACs drive the accumulation of
nascent microvilli into a mature BB while promoting the integrity of canonical cell junctions. Using state-of-the-
art microscopy and novel epithelial model systems, we will: (Aim 1) define the subcellular mechanism of IMAC
formation, (Aim 2) determine if transjunctional IMACs promote microvillus accumulation, and (Aim 3) determine
if transjunctional IMACs promote the integrity of canonical cell junctions. These studies will reveal how the
enterocyte surface becomes maximally packed with microvilli over the full time-course of differentiation and in
doing so, offer new paradigms for understanding apical morphogenesis.

Public health relevance
NARRATIVE The epithelial cells that line the intestinal tract build finger-like protrusions referred to as ‘microvilli’, which extend into the gut lumen and play essential roles in nutrient absorption and protection against infection. Despite occupying a critical physiological interface in the gut, there is little information on how microvilli are built and organized. The proposed studies seek to elucidate molecular pathways that control the assembly and organization of these protrusions during intestinal epithelial differentiation, and thus generate insight on the basis of human diseases characterized by loss of microvilli, which include enteric infections and inherited pathologies such as microvillus inclusion disease.